ANIMAL MODEL DEVELOPMENT

The focus of the NIH Animal Genetic Resource (NIHAGR) is the development of new animal models for the biomedical research community utililizing classical genetic techniques supplemented by molecular genetic procedures. This work has resulted in a relatively large number of new models which have proven to be of value for studies exploring immune regulation in infectious disease states as well as during tumor development. Other models developed by the NIHAGR are being used to study the interrelationship between obesity and hypertension in the rat and its role in the development of Insulin Independent Diabetes mellitus. The Resource has also developed models in the rat which have value for the study of chemical addiction in humans. - Mice, Rats, obesity, hypertension, immunology, behavior.